Integrated Treatment for Enhancing Growth in Recovery during Adolescence (InTEGRA)

Project Summary/Abstract: Approximately 10% of adolescents are diagnosed with an alcohol or other drug (AOD) use
disorder each year in the U.S. Such disorders increase risk of premature mortality and morbidity and confer negative effects
on social and neurocognitive functioning, biobehavioral maturation, and the achievement of developmental milestones.
Despite advances in intervention research for adolescent AOD,1-4 the science base, in general, has lagged sorely behind that
of adults.5-7 Furthermore, few studies have tested effective treatment models that can sustain youth remission over time as
adolescents navigate the high-risk period of emerging adulthood. While many different interventions for youth AOD
disorders have been developed and tested producing similar results,1 absent is one that links youth to ubiquitous, freely
available, community recovery resources, such as Alcoholics Anonymous (AA) or Narcotics Anonymous (NA). Systematic
clinical linkages to these 12-step community resources have the potential to extend and enhance formal interventions’ effects
because they have been shown to mobilize the same kinds of therapeutic mechanisms mobilized by formal treatments (e.g.,
by enhancing motivation/self-efficacy, changing social networks),8, 9 but do so for free and over the long-term in the
community.10, 11 The evidence in support of adult participation in these organizations has grown substantially with findings
supporting clinic-based Twelve-Step Facilitation (TSF)12-17 interventions and community 12-step group participation12, 18, 19
in enhancing remission rates while reducing health costs.20-22 In more recent years, several naturalistic studies have examined
the clinical and public health utility of systematically linking young people with these prevalent resources 23-31 showing
long-term benefits from AA/NA8, 28, 30 and in reducing health care costs,31 similar to adults. While dozens of studies have
tested adult TSF efficacy,17, 32, 33 until recently, none had tested youth TSF efficacy, despite 80% of youth programs using
12-step practices and linkage.28, 34 In the first NIH-funded study to develop and test a replicable, manualized, adolescent
TSF, however, we found that youth randomly assigned to receive a novel combination treatment (Integrated Treatment for
Enhancing Growth in Recovery during Adolescence [InTEGRA]) that incorporated key elements of TSF in addition to
Motivational Enhancement Therapy/Cognitive-Behavioral Therapy (MET/CBT), showed moderate-large clinically
meaningful advantages that grew across follow-ups when compared to youth receiving MET/CBT alone. They also attended
two to three times as many 12-step meetings during treatment, with 12-step attendees showing significantly greater
abstinence.35 Given initial efficacy and potential for widespread adoption and implementation,34, 36, 37 InTEGRA now needs
to be tested in a larger sample, with additional emphases on how (i.e., mechanisms) and for whom (i.e., moderators) it
works. Using a type I hybrid implementation-effectiveness design,38 this study proposes to: 1. Conduct an adequately
powered (N=294) Phase II RCT to test InTEGRA efficacy relative to MET/CBT alone across two clinical sites. 2.
Investigate mechanisms of behavior change (e.g., 12-step involvement; social networks, self-efficacy) through which
InTEGRA confers benefit. 3. Explore moderators (e.g., age, psychiatric/AOD severity) of InTEGRA’s effects across a one-
year follow-up. 4. Explore barriers and facilitators to the intervention’s widespread implementation.

Public health relevance
R.220.8. Project Narrative Relevance to Public Health: Substance use disorders among youth present a tenacious public health problem and despite considerable advances in the development of efficacious treatments, novel treatments are sorely lacking. Interventions that emphasize cognitive-behavioral skills building and address motivation, but also continuing care and social recovery capital, such as the combined, Integrated Treatment for Enhancing Growth in Recovery during Adolescence (InTEGRA), show promise in helping sustain remission in cost-effective ways but need testing in larger samples for appropriateness and efficacy. Using a hybrid type I effectiveness-implementation-design, this study tests the efficacy, mechanisms, and moderators of the promising developmentally appropriate InTEGRA treatment for adolescents while investigating facilitators and barriers to widespread implementation.